A wastewater approach to viral transmission, evolution, and ecology

PROJECT SUMMARY
Monitoring viral dynamics at the community level is crucial for effective public health responses, yet remains
a significant challenge. Understanding how viruses transmit, evolve, and interact ecologically within populations
is essential for predicting and managing outbreaks. Traditional viral surveillance methods, which rely primarily
on clinical testing and analysis of samples from symptomatic individuals, have been invaluable but have
recognized constraints. These approaches often miss asymptomatic cases, are slow to detect new variants, and
fail to capture the full spectrum of viral behavior within communities. Consequently, there is a pressing need for
more comprehensive monitoring strategies that can provide a more complete and timely understanding of viral
dynamics at the population level.
Wastewater-based surveillance has emerged as a promising complement to traditional surveillance methods,
offering a unique window into community-wide viral activity. By analyzing sewage, researchers can detect viral
genetic material shed by both symptomatic and asymptomatic individuals, providing a more inclusive snapshot
of infection patterns. However, current wastewater surveillance research faces two main challenges: first,
translating wastewater data into precise epidemiological insights for quantitative understanding and prediction
of viral transmission; and second, leveraging this approach to understand variant evolution and ecology within
communities. As viruses mutate and generate diverse variant populations, how different variants compete,
coexist, or give rise to new strains at the community level remains largely unexplored.
To address these challenges, the long-term goal of this project is to establish a cohesive framework
for understanding and predicting viral dynamics at the community level. By integrating wastewater
surveillance, computational modeling, and genomic sequencing, we will pursue three specific aims: 1) Develop
advanced models combining within-host viral kinetics and between-host transmission dynamics to improve
wastewater data interpretation and prediction of viral transmission; 2) Examine the evolutionary dynamics of
variant transitions, focusing on the Delta-to-Omicron shift as a case study; and 3) Analyze variant community
dynamics and ecological interactions across multiple cities to understand variant succession patterns and
biodiversity, and predict the emergence of new dominant variants.
This integrated approach will significantly advance our understanding of viral dynamics at the community
level, enhancing our ability to detect new viral threats early, track their evolution, and understand their ecological
interactions. Through strategic collaboration with the Wastewater Action Plan committee of the Texas Epidemic
Public Health Institute, this work will influence public health policy and decision-making, strengthen pandemic
preparedness, and improve our capacity to respond effectively to future viral outbreaks.

Public health relevance
NARRATIVE This research enhances public health by developing an advanced wastewater-based epidemiological framework for early detection and forecasting of infectious viral diseases. By integrating computational modeling and next- generation sequencing with wastewater surveillance, our approach offers a non-invasive tool for understanding viral transmission, evolution, and ecology at the community level. Grounded in fundamental principles of viral dynamics, the methodologies and models developed are adaptable to pathogens beyond SARS-CoV-2, which will enhance public health infrastructure and pandemic preparedness.